Development of functional plasticity in a simplex retina.

PROJECT SUMMARY/ABSTRACT:
Retinal sensitivity over the full range of environmental lighting conditions, from dark to bright, is mediated by
rod and cone photoreceptors and is fundamental to vision. Importantly, when one type of photoreceptor dies,
as in retinal diseases like macular degeneration or retinal dystrophy, the remaining photoreceptor type is
unable to fill-in the gap in functionality that remains. This often leads to visual impairment or blindness.
Disorders of the visual system that selectively damage photoreceptors affect millions of people worldwide. In
the United States alone, age-related macular degeneration is the leading cause of blindness for people over 65
– an affected population that is projected to double in the next 25 years. Other rarer conditions, like retinitis
pigmentosa and retinal dystrophies, affect ~1 in 4000 or 5000 people, respectively. Predictably, rescuing lost
function in photoreceptors is a major goal in vision restoration efforts. However, the majority of mammalian
retinas are “duplex” and have mixed rod-cone populations. Duplex retinas experience a “duality barrier” to
restoring function after the selective loss of one type of photoreceptor. Retinas of other vertebrate organisms
present us with exciting new opportunities to understand how we could possibly overcome the “duality barrier”.
Here, we propose to investigate the pure-rod retina of Leucoraja erinacea (Little Skate), in which a single class
of photoreceptor can subserve the full range of rod and cone vision. We have a limited understanding of what
environmental and developmental factors govern this functional plasticity in the skate retina, but a detailed
knowledge of how this is achieved could hold the key to expanding the functional repertoire of surviving rods or
cones in diseased duplex retinas. Based on previous work and preliminary data, we hypothesize that this
functional plasticity is driven by developmental programs under the influence of early sensory input, leading to
the adaptations observed in the mature retinal circuit. We will test our hypothesis in the following specific aims:
Aim 1: To determine what molecular and structural factors govern the establishment of cell circuitry in a
functionally plastic single photoreceptor type retina during development. The objective of Aim 1 is to
understand how early and late developmental stages shape the establishment of functional plasticity. Aim 2:
To determine the role of sensory experience and light adaptation in the formation and function of rod circuitry
on the anatomical, physiology, and molecular level. The objective of Aim 2 is to understand the effects of
sensory deprivation on the development of a functionally plastic retinal circuit. The proposed research is
innovative because it steps away from a traditional mixed rod-cone retina model system and instead studies
the functional adaptation of rod circuitry in a naturally occurring pure-rod retina model system. It is significant
because it will reveal fundamental principles of functional adaptation in a single photoreceptor type retina,
which can lead to novel vision restoration efforts focused on expanding the functionality of surviving
photoreceptors.

Public health relevance
PROJECT NARRATIVE: In duplex retinas, the processing of visual information under scotopic and photopic light conditions is separated between the rod and cone systems, but in the simplex retina of L. erinacea, a single rod-like photoreceptor can function over the full range of illumination. We hypothesize that this functional plasticity is driven by early sensory input, which pushes developmental programs towards the adaptations observed in the mature retinal circuit. The proposed project is relevant to public health because it will: 1) elucidate how a pure-rod vertebrate retina is able to cover a wide range of light intensities, 2) provide important insights into the selective pressures that control the rod-cone balance in vertebrates, and 3) lead to a better understanding of ways to expand the functional repertoire of surviving photoreceptors in diseased duplex retinas.